Computational tools and resources to study alternative splicing and mRNA isoform variation

PROJECT SUMMARY
The central objective of this project is to develop broadly applicable computational tools and resources for
studying pre-mRNA alternative splicing (AS) and mRNA isoform variation. AS is a prevalent mechanism for
generating regulatory and functional diversity. Almost all multi-exon genes in mammalian genomes undergo AS,
resulting in mRNAs that vary in their exon composition. Widespread changes in AS occur in development, cell
differentiation, and disease. However, many questions remain about the patterns, regulation, and functions of
AS. Rapid accumulation of large-scale RNA-seq data in public repositories, emergence of new long-read
sequencing strategies for transcriptome analysis, and recent advances in deep learning techniques create
exciting opportunities for omics and big data approaches to uncover new regulatory and functional features of
AS. To make full use of these powerful datasets and technologies, new computational tools are urgently needed.
Our lab has an outstanding track record in developing and disseminating widely adopted algorithms and
computational tools for characterizing AS and mRNA isoform variation. In this R01 project, building on that
expertise, we will develop new computational tools and resources to study intron retention – a still poorly
understood mechanism of gene regulation in human cells – and characterize genetically regulated intron
retention events in the human population (Aim 1), and to delineate AS patterns and mRNA isoform variation
using long-read RNA-seq data of bulk tissues (Aim 2) and single cells (Aim 3). The resulting user-friendly,
scalable tools as well as associated data resources will substantially enhance the ability of biomedical
researchers to study AS and transcriptome complexity using in-house and public datasets in diverse normal and
diseased contexts. All software developed in this project will be made open source and freely available to the
research community. We will leverage our extensive network of expert collaborators and broad user base to
enhance the development, testing, and dissemination of these computational tools. Our efforts will be integrated
with our long-standing interest in the biology of AS and mRNA isoform regulation, ensuring that our work
addresses important biomedical questions and serves unmet technological needs. Importantly, in each aim the
development of computational tools and resources will synergize with their applications to questions about the
variation, regulation, and functions of AS. Overall, we expect that our proposed R01 project will provide powerful
and widely used computational tools and resources for studying AS in mammalian transcriptomes.

Public health relevance
PROJECT NARRATIVE Pre-mRNA alternative splicing (AS) generates enormous regulatory and functional diversity from a finite set of genes in mammalian genomes. This project aims to develop broadly applicable computational tools and resources to study AS and mRNA isoform variation in bulk tissues and single cells, leveraging population-scale short-read RNA-seq datasets and emerging long-read RNA-seq technologies. Using these computational tools and resources, scientists can address important questions regarding the variation, regulation, and functions of AS, and elucidate how changes in AS impact human traits and diseases.